Function of V-ATPases in Breast Cancer Metastasis

Project Summary
Metastasis is the leading cause of mortality from breast cancer, but effective therapies to inhibit metastasis
have not been identified. Identifying novel targets to limit breast cancer metastasis would therefore fill an
important unmet clinical need. Metastasis involves the escape of tumor cells from the primary site into the
circulation and invasion of these cells into secondary sites. Both of these processes depend upon tumor cell
invasiveness, a process in which V-ATPases have recently been implicated. The long-term objective of this
research is to determine the role of V-ATPases in breast tumor metastasis. V-ATPases are ATP-dependent
proton pumps that function in both intracellular compartments and the plasma membrane in a variety of cellular
processes. Targeting of V-ATPases to different cellular membranes is controlled by isoforms of subunit a (a1-
a4), with a3 and a4 capable of targeting V-ATPases to the plasma membrane. We have identified V-ATPases
in the plasma membrane of highly invasive breast tumor cells (MDA-MB231, MCF10CA1a, 4T1) but not in
poorly invasive lines (MCF10a, MCF7). Moreover, the in vitro invasiveness of only the highly invasive lines is
inhibited by specific V-ATPase inhibitors. In addition, highly invasive cells express higher levels of the a3 or a4
isoforms, and knock-down of these isoforms using isoform-specific siRNAs inhibits both invasion and plasma
membrane localization of the V-ATPase. Importantly, overexpression of a3 in non-invasive MCF10a cells
significantly increases plasma membrane V-ATPases and invasiveness. Recently, we have shown that
selective inhibition of plasma membrane V-ATPases inhibits invasion of MB231 cells, that a3 is up-regulated in
human breast tumor samples and is expressed at the highest levels in invasive breast carcinoma relative to
solid tumors and normal tissue. These results suggest that up-regulation of a3 or a4 in breast tumor cells
targets V-ATPases to the plasma membrane, where they function to increase invasiveness. Our first objective
is to prepare antibodies directed against extracellular epitopes of the V-ATPase that are capable of inhibiting
cell surface V-ATPases. Our previous studies employing inhibitory antibodies directed against extracellular
epitope tags provide a strong proof of principal for this aim. We predict that these inhibitory antibodies will be
effective at reducing breast tumor cell invasiveness. Our second objective is to test the hypothesis that plasma
membrane and a3 or a4-containing V-ATPases function in breast tumor metastasis in vivo. This will be
accomplished using a mouse xenograft model of breast cancer metastasis in collaboration with Dr. Charlotte
Kuperwasser, co-Principal Investigator, who is an expert in the analysis of breast cancer metastasis using such
models. We will determine the effect on metastasis of the inhibitory antibodies prepared in Aim 1 as well as
disruption of a subunit isoforms in highly invasive breast cancer cell lines using CRISPR/Cas9.
Accomplishment of these aims will provide a critical test of plasma membrane and a3 or a4-containing V-
ATPases as novel therapeutic targets to limit breast cancer metastasis.

Public health relevance
Project Narrative The proposed research is relevant to human health because metastasis is the leading cause of death from breast cancer, but effective therapies to limit metastasis have not been identified. Our data indicate that the V- ATPase, a proton pump involved in a number of basic cellular processes, functions at the plasma membrane of breast tumor cells to increase their invasiveness, and thus represents an important and novel anti-metastatic target to limit breast cancer metastasis. The proposed research will directly test the function of plasma membrane and a3 or a4-containing V-ATPases in in vivo metastasis of breast tumor cells and will develop anti- V-ATPase inhibitory antibodies as potential anti-metastatic therapeutic agents to limit breast cancer metastasis, making this work highly relevant to the mission of NCI.